Control of extracellular matrix remodeling by CD29+ astrocytes

PROJECT SUMMARY/ABSTRACT
Remodeling of the extracellular matrix (ECM) is a central mechanism by which central nervous system (CNS)
reward substrates, such as the nucleus accumbens (NAc), adapt to unpredictable stressors in the environment.
The ECM is a spatially, molecularly, and cellularly heterogeneous structure that impacts neural activity, cell-cell
interactions, and blood-brain barrier integrity. However, exposure to repeated unpredictable stress leads to
molecular and cellular reorganization of the ECM, which influences circuit-level adaptations to stress guiding
neural activity and behavior. ECM remodeling is partially controlled by integrins: transmembrane receptors that
regulate the ECM by anchoring ECM-associated peptides to multiple cell types. Cellularly, the ECM consists of
neuronal processes and also the endfeet of astrocytes, which are CNS-resident glial cells. Astrocytes make
contacts throughout the ECM by expressing multiple integrins that actively participate in ECM remodeling.
Through these intimate interactions within the ECM, astrocytes are poised to control neural activity and behavior.
However, the mechanisms and cell-cell interactions by which astrocytes shape the NAc ECM in response to
unpredictable stress are largely unknown. In PREVIOUS RESEARCH EFFORTS I focused on characterizing
the responses of astrocyte subsets in the CNS in response to inflammation. I identified the b1 integrin CD29 as
a top marker expressed by astrocytes throughout the CNS. CD29 participates in multiple complexes with other
integrins that affect ECM organization. My previous data suggest that CD29+ astrocytes might be composed of
heterogeneous subsets that play complementary roles in remodeling the ECM by interacting with distinct cell
types. However, it has been historically challenging to rapidly study the interactions of astrocyte subsets in vivo.
To this end, I recently developed a new technique called RABID-seq that profiles astrocyte interactions with other
cells at high throughput, on the genome-wide scale, and with single-cell transcriptomic precision. Thus, RABID-
seq is a candidate tool to define the interactions of CD29+ astrocyte subsets in the ECM in response to
unpredictable stress. In this proposal, I AM PURSUING A NEW RESEARCH DIRECTION to identify how
exposure to unpredictable stress shapes CD29+ astrocyte interactions, localization, and function. I hypothesize
that defined subsets of CD29+ astrocytes regulate distinct ECM domains that influence behavioral responses to
unpredictable stress. I propose to test this hypothesis in the following Specific Aims. In Aim 1, I will define the
interactions of integrin-expressing CD29+ astrocyte subsets within the NAc in response to acute and chronic
unpredictable stress using RABID-seq and CITE-seq. In Aim 2, I will spatially map the ECM domains occupied
by each subset of CD29+ NAc astrocytes via spatial transcriptomics and CD29 cKO mice to uncover how CD29+
astrocytes remodel the ECM in response to stress. In Aim 3, I will define how CD29+ NAc astrocytes regulate
the activity of parvalbumin+ interneurons in a reward-seeking paradigm after exposure to unpredictable stress.
IN SUMMARY, I will study how stress affects the interactions, location, and function of NAc CD29+ astrocytes.

Public health relevance
PROJECT NARRATIVE Chronic unpredictable stress is an environmental risk factor for developing multiple diseases and influences the plasticity of reward substrates including the nucleus accumbens (NAc). The objective of this project is to study a population of NAc astrocytes expressing the b1 integrin, CD29, a pivotal receptor in ECM organization and a candidate mechanism impacting NAc plasticity, neural activity, and behavior. I will utilize single-cell multi-omic tools, spatial transcriptomics, animal behavioral paradigms, and in vivo calcium imaging to examine how CD29+ astrocyte subsets influence cell-cell interactions, ECM spatial organization, and neural activity in the NAc in response to unpredictable stress, which could lead to the identification of novel mechanisms relevant for mental health.